MEDICAL VERSUS OPERATIVE MANAGEMENT OF RENOVASCULAR HYPERTENSION

This is the 19th year of controlled study of surgery vs medical therapy of renovascular HTN. Near completion oat this point and is anticipated the study will be completed within 6 months. There appears to be a trend for better outcome in the surgically treated group.